Fluorescence Microscopy

In meeting the goals and objectives of FMIC, the center continues to:

-Service and maintain state-of-the-art equipment for unlimited access by intramural scientists.
-Provide investigator training in the use and analysis of fluorescence and optical-based techniques.
-Develop and optimize experimental protocols in collaboration with intramural scientists.
-Maintain and develop state-of-the-art analysis tools and protocols in collaboration with investigators
-Monitor and incorporate emerging fluorescence and optical technologies that will support the mission of NIEHS into FMIC.

During this fiscal year, FMIC has collaborated and supported 44 Principle Investigators from 8 branches/laboratories within the NIEHS DIR.

Some publications from this FY resulting from work in the center is listed in the bibliography below:

Bibliography

Fan W, Li X. Using BODIPY FL-Sphingolipid Analogs to Study Sphingolipid Metabolism in Mouse Embryonic Stem Cells. Bio Protoc. 2022;12(22). Epub 2022/12/20. doi: 10.21769/BioProtoc.4555. PubMed PMID: 36532684; PMCID: PMC9724015.

Lin YP, Scappini E, Landaverde C, Parekh-Glitsch F, Tucker CJ, Mirams GR, Parekh AB. Nuanced Interactions between AKAP79 and STIM1 with Orai1 Ca(2+) Channels at Endoplasmic Reticulum-Plasma Membrane Junctions Sustain NFAT Activation. Mol Cell Biol. 2022:e0017522. Epub 2022/11/02. doi: 10.1128/mcb.00175-22. PubMed PMID: 36317924.

Yokobori K, Negishi M. Ser815 Phosphorylation stabilizes the androgen receptor homodimer and stimulates ER-stress induced cell death. Biochem Biophys Res Commun. 2022;639:54-61. Epub 2022/12/06. doi: 10.1016/j.bbrc.2022.11.083. PubMed PMID: 36470072.

Dickson MJ, Gruzdev A, DeMayo FJ. iCre recombinase expressed in the anti-Mllerian hormone receptor 2 gene causes global genetic modification in the mouse. Biol Reprod. 2023. Epub 2023/02/02. doi: 10.1093/biolre/ioad012. PubMed PMID: 36721982.

Dudek SM, Phoenix AN, Scappini E, Shepeleva DV, Herbeck YE, Trut LN, Farris S, Kukekova AV. Defining hippocampal area CA2 in the fox (Vulpes vulpes) brain. Hippocampus. 2023. Epub 20230509. doi: 10.1002/hipo.23546. PubMed PMID: 37159095.

Grodzielski M, Cidlowski JA. Glucocorticoids regulate thrombopoiesis by remodeling the megakaryocyte transcriptome. J Thromb Haemost. 2023. Epub 20230617. doi: 10.1016/j.jtha.2023.06.012. PubMed PMID: 37336437.

Inoue K, Bostan H, Browne MR, Bevis OF, Bortner CD, Moore SA, Stence AA, Martin NP, Chen SH, Burkholder AB, Li JL, Shaw ND. DUX4 double whammy: The transcription factor that causes a rare muscular dystrophy also kills the precursors of the human nose. Sci Adv. 2023;9(7):eabq7744. Epub 2023/02/18. doi: 10.1126/sciadv.abq7744. PubMed PMID: 36800423; PMCID: PMC9937577.

Li R, Wang T, Marquardt RM, Lydon JP, Wu SP, DeMayo FJ. TRIM28 modulates nuclear receptor signaling to regulate uterine function. Nat Commun. 2023;14(1):4605. Epub 20230801. doi: 10.1038/s41467-023-40395-7. PubMed PMID: 37528140; PMCID: PMC10393996.

Qu W, Yan Y, Gerrish K, Scappini E, Tucker CJ, Dixon D, Merrick BA. Chronic PFOA exposure in vitro causes acquisition of multiple tumor cell characteristics in rat liver cells. Toxicol In Vitro. 2023:105577. Epub 20230225. doi: 10.1016/j.tiv.2023.105577. PubMed PMID: 36849026.

Radzicki D, Chong S, Dudek SM. Morphological and molecular markers of mouse area CA2 along the proximodistal and dorsoventral hippocampal axes. Hippocampus. 2023. Epub 2023/02/11. doi: 10.1002/hipo.23509. PubMed PMID: 36762588.

Samadi M, Hales CA, Lustberg DJ, Farris S, Ross MR, Zhao M, Hepler JR, Harbin NH, Robinson ESJ, Banks PJ, Bashir ZI, Dudek SM. Mechanisms of mGluR-dependent plasticity in hippocampal area CA2. Hippocampus. 2023. Epub 20230327. doi: 10.1002/hipo.23529. PubMed PMID: 36971428.

Song S, Tu D, Meng C, Liu J, Wilson B, Wang Q, Shih YI, Gao HM, Hong JS. Dysfunction of the noradrenergic system drives inflammation, -synucleinopathy, and neuronal loss in mouse colon. Front Immunol. 2023;14:1083513. Epub 2023/02/28. doi: 10.3389/fimmu.2023.1083513. PubMed PMID: 36845109; PMCID: PMC9950510.

Tu D, Velagapudi R, Gao Y, Hong JS, Zhou H, Gao HM. Activation of neuronal NADPH oxidase NOX2 promotes inflammatory neurodegeneration. Free Radic Biol Med. 2023. Epub 20230302. doi: 10.1016/j.freeradbiomed.2023.03.001. PubMed PMID: 36870375.

Zhao ML, Stefanick DF, Nadalutti CA, Beard WA, Wilson SH, Horton JK. Temporal recruitment of base excision DNA repair factors in living cells in response to different micro-irradiation DNA damage protocols. DNA Repair (Amst). 2023;126:103486. Epub 20230322. doi: 10.1016/j.dnarep.2023.103486. PubMed PMID: 37028218.

Zhou J, Li J, Papaneri AB, Cui G. AJ76 and UH232 as potential agents for diagnosing early-stage Parkinson's disease. Neuropharmacology. 2023;226:109397. Epub 2023/01/10. doi: 10.1016/j.neuropharm.2022.109397. PubMed PMID: 36623805.

Zhou R, Chen SH, Zhao Z, Tu D, Song S, Wang Y, Wang Q, Feng J, Hong JS. Complement C3 Enhances LPS-Elicited Neuroinflammation and Neurodegeneration Via the Mac1/NOX2 Pathway. Mol Neurobiol. 2023. Epub 20230603. doi: 10.1007/s12035-023-03393-w. PubMed PMID: 37268807.